Selenium Supplementation for Moderate-Severe Ulcerative Colitis Flares

Selenium deficiency is common in ulcerative colitis (UC), even during periods of quiescent disease, and
deficiency of selenium in UC is associated with an increased risk for disease flares and need for colectomy.
Recent evidence demonstrates that coloncytes can directly uptake selenium and use it to synthesize
selenoprotein-P (SELENOP), which is secreted basolaterally into the colonic microenvironment. Myeloid specific
loss of SELENOP, but not epithelial specific loss of SELENOP, results in increased susceptibility to induction of
colitis. Through large integrated human single-cell and spatial transcriptomics datasets, we observed an inverse
association between myeloid SELENOP expression and disease activity in UC. In a prospectively recruited
cohort of biologic treated moderate-severe UC patients, non-responders to IL23 blockade had significantly lower
myeloid SELENOP expression and increased myeloid ferroptosis. These myeloid transcriptional changes for
SELENOP and ferroptosis were not seen for non-responders to anti-TNF or anti-trafficking therapy. In-vitro data
confirmed effects of selenium exposure for increasing anti-ferroptosis pathways in myeloid cells. Trace element
profiling of human tissue and blood confirmed selenium deficiency in active UC patients in colonic tissue biopsies,
but not blood, demonstrating a need for colonic microenvironmental selenium supplementation. A small prior
placebo-controlled clinical trial in mild-moderate UC demonstrated improved symptom activity with selenium
supplementation, but proof-of-concept data is lacking in moderate-severe UC. We aim to complete a proof-of-
concept clinical trial for selenium supplementation in moderate-severe UC patients starting advanced biologic or
small molecule therapy. Using human biospecimens from this trial, we aim to develop an exposure-response
model for selenium and study changes in myeloid ferroptosis with selenium supplementation in UC. The data
generated from this proposal will be used to design and power a larger multi-center clinical trial to confirm
clinical effects of selenium supplementation in moderate-severe UC and establish whether this clinical effect is
greater for patients being treated with anti-IL23 biologics.

Public health relevance
Selenium deficiency in ulcerative colitis is common and associated with an increased risk for disease flares and need for surgery. A prior clinical trial has demonstrated that selenium supplementation may improve symptom activity, but well powered clinical trials are lacking for patients with more severe disease activity using objective measures of inflammation. We aim to complete a proof-of-concept clinical trial in moderate-severely active ulcerative colitis to determine whether selenium supplementation may be an effective treatment strategy for improving symptom activity and colonic inflammation.